Transcranial Magnetic Stimulation to Improve Functioning in Veterans with PTSD

Posttraumatic Stress Disorder (PTSD) is an often chronic and disabling condition prevalent in the Veteran
population. Many effective treatments, such as medications and psychotherapy, for PTSD have been
developed and deployed in the VA. Other more procedural or “somatic” treatments appear promising but are
understudied. One such understudied somatic treatment is repetitive transcranial magnetic stimulation (TMS).
TMS has shown clear efficacy in the treatment of depression, and the U.S. Food and Drug Administration has
approved TMS for this indication. Beyond this, early studies indicate that TMS is a highly promising somatic
therapy for PTSD.
While functional improvement and recovery are central goals for PTSD treatment, the majority of PTSD
treatment studies do not include measures of functional improvement. Moreover, none of the TMS treatment
studies in PTSD have examined functional outcomes. Therefore, research is needed to determine: (1) if TMS
is an effective treatment for PTSD; and (2) if TMS is associated with functional improvement.
The immediate objective of this study is to determine whether TMS is an effective treatment for PTSD. We will
also compare the efficacy and functional improvement associated with treatment. The long-term goal is to
improve the health of Veterans with PTSD through development of effective treatments.
We seek to study several interrelated research questions. First, is transcranial magnetic stimulation delivered
to the right dorsolateral prefrontal cortex of Veterans with PTSD more effective in decreasing symptoms of
PTSD compared to sham treatments? Second, does transcranial magnetic stimulation delivered to the right
dorsolateral prefrontal cortex effective for improving functioning Veterans with PTSD?
We propose a four-year study to answer these questions regarding the use of TMS for the treatment of PTSD.
During the study, 91 participants from the White River Junction VA Medical Center will be randomized to either
TMS or sham TMS; all TMS will be applied to the right dorsolateral prefrontal cortex. All participants will meet
DSM-V criteria for PTSD. The primary outcome will be change in severity of PTSD symptoms as measured as
a continuous variable using the Clinician Administered PTSD Scale (CAPS). Secondary outcomes include
function, depressive symptoms, and side effects.

Public health relevance
Posttraumatic Stress Disorder (PTSD) is a common and serious condition affecting many Veterans. There are effective treatments for PTSD, but additional treatments are needed in order to better serve Veterans suffering from PTSD. Transcranial magnetic stimulation is one such promising treatment. It involves use of powerful magnet to stimulate the specific brain regions in Veterans with PTSD. Transcranial magnetic stimulation has been shown effective in treating depression, but currently it is unclear if it is an effective treatment for PTSD. We propose to conduct a randomized clinical trial in 91 Veterans with PTSD comparing the effectiveness of transcranial magnetic stimulation treatment and sham transcranial magnetic stimulation in treating PTSD.